CULTURED NEURON PROBE

The objective of this contract is to determine the feasibility of establishing connections with specific target neuronal populations in the mammalian central nervous system (CNS) by developing and evaluating a cultured neuron probe.